Circuit-based mechanisms of neuronal vulnerability in the adult EC

Project summary/abstract.
Entorhinal cortex layer II (ECII) neurons are some of the first cells to degenerate in Alzheimer’s Disease (AD). ECII
axons form the perforant pathway and are the major cortical input into the hippocampus. The perforant pathway supports
memory formation and spatial navigation throughout life, and loss of this input is consistent with the cognitive deficits
that present early in AD. To mimic the loss of this input in AD, the Jankowsky lab created a chemogenetic mouse model
of perforant pathway disruption in which a subset of ECII neurons express an engineered chloride channel (GlyCl) to
prevent the generation of action potentials. We unexpectedly discovered that entorhinal neurons were highly vulnerable to
silencing. Shortly after being inactivated, many ECII neurons retract their axons from the dentate gyrus, express pro-
apoptotic proteins, and then are eliminated from the circuit. We observed similar neurodegeneration after eliminating
neurotransmitter release with tetanus toxin (TeTX), confirming that neuronal loss is not an artifact of GlyCl activation.
Further, this silencing-induced degeneration is not shared by other brain regions, as neither the pre/parasubiculum nor
retrosplenial cortex exhibit cell loss after neuronal inactivation. This suggests that specific features of the entorhinal
cortex may confer neuronal vulnerability to inactivity. One possible vulnerability could be related to the formation of
entorhinal-hippocampal circuit. We noted that the pattern of ECII degeneration after silencing was strikingly similar to the
processes that guide to refinement of the perforant pathway during development. In early post-natal periods, inactive ECII
neurons are pruned from the circuit in a process that is mediated by local differences in activity, referred to as activity-
dependent competition. Projections are only pruned when neurons are sparsely inactive - when all cells are equally
inactive, none are removed. This proposal will test two hypotheses about the cellular mechanism driving neuronal death in
the mature entorhinal cortex. Aim 1 will determine whether activity-dependent competition persists in the adult ECII.
Pharmacological and genetic approaches will be used to modulate relative activity levels to determine how cell death is
influenced by activity differences between neighboring cells. Aim 2 will determine whether post-synaptic partners
promote the survival of ECII neurons. Our preliminary data suggests that eliminating neurotransmitter release from ECII
neurons – without blocking action potentials - is sufficient to induce degeneration. I will therefore use pharmacological
and genetic approaches to both reduce neurotransmitter binding in dentate granule cells and eliminate their ability to fire
action potentials in response to ECII input. This will test whether neurotransmitter-mediate signaling, or post-synaptic
activity itself, is required for ECII neuron survival. Data from these aims will determine how activity disruption may
mediate cell death in the adult brain. Further, these data may suggest that mechanisms which drive cell death during
postnatal development are not necessarily limited to critical periods but may persist into adulthood within certain
pathways. Understanding these mechanisms may inform future studies on neurodegenerative disease and how circuit
disruption may contribute to neuronal loss.

Public health relevance
Project Narrative Chemogenetic inactivation of entorhinal cortex layer II (ECII) neurons unexpectedly induces degeneration of the silenced neurons. ECII was uniquely sensitive to activity disruption among regions we tested, reminiscent of its selective vulnerability in Alzheimer’s disease. Here I will use genetic, pharmacological, and electrophysiological approaches to test competing hypotheses that address how changes in normal circuit activity may drive cell death in ECII.